Roles of mechanotransduction in organ regeneration and fibrosis

Project Summary
Environmental biomechanical cues play a critical role in cell growth and functional homeostasis.
Many human diseases, such as organ fibrosis, cardiovascular diseases, and cancers, have been
associated with aberrant biomechanical cues that promote disease progression. However, how
cells sense and propagate biomechanical cues into biochemical signals, a process known as
mechanotransduction, is poorly understood. In particular, the precise signaling transduction
mechanisms and transcriptional outputs of mechanotransduction remain unknown. Unveiling the
roles and signaling cascades of mechanotransduction is important for understanding fundamental
development and disease mechanisms and for advancing therapeutic strategies.
I have been developing a research program to elucidate the roles and mechanisms of
mechanotransduction in tissue growth control and disease development, with a current focus on
how mechanotransduction controls regeneration and fibrosis during organ injury and repair. The
main challenge in understanding mechanotransduction in this disease context is the lack of
knowledge of mechanotranscriptomes and signaling cascades that are triggered by a combination
of force-, cell-, and microenvironment-specific factors. In this proposal, I aim to answer 3 main
questions to advance our understanding in the field: (i) what role does mechanotransduction play
in regulating cellular functions and transcriptomes, particularly in the context of tissue repair? (ii)
what are the signaling cascades that connect plasma membrane mechanosensors to
mechanotranscriptomes? (iii) how do biomechanical cues and wound-healing signals integrate to
control cellular functions and transcriptomes?
I will use endothelial cells and the liver as my main models to study these questions, as
they are classical models for studying mechanotransduction and tissue repair, respectively. We
will characterize endothelial mechanotransduction for its roles in liver regeneration and fibrosis
mainly using (i) in vitro or ex vivo bioengineered models with human primary endothelial cells,
and (ii) in vivo mouse models of liver injury. My research program will also include similar studies
of fibroblast mechanotransduction and lung regeneration and fibrosis.
I anticipate that my research program will advance the fundamental understanding of
mechanotransduction in normal and diseased contexts, providing opportunities for identifying new
druggable targets from mechano-signaling cascades for organ fibrosis and other diseases with
aberrant tissue mechanics.

Public health relevance
Project Narrative My research program aims to understand the molecular mechanisms by which biomechanical forces control tissue regeneration and fibrosis upon organ injury. I expect this research program will advance therapeutic strategies for organ fibrosis and other diseases with aberrant tissue mechanics via providing precise targets in cellular mechanotransduction pathways.